The Protein Data Bank support

NCI funding to support the Protein Data Bank which serves as the primary international repository for the experimentally determined macromolecular structural data including proteins, nucleic acids, carbohydrates, peptides and viruses.